Elucidating Mechanisms and Design Principles for Chemically Inducible Expression Modulation

PROJECT SUMMARY
Molecular tools that can precisely modulate gene expression provide unique opportunities to both study the
relationships between genotype and phenotype, as well as correct the pathologies caused by dysregulated gene
expression. However, restricting the activity of these tools to the appropriate times or cell types remains a major
hurdle to their effectiveness at interrogating biology and their safety in therapeutic settings. Our research
program’s main goal is to elucidate the design principles for synthetic signaling systems that enable precision
control of gene expression and, in doing so, to create fundamental insights into the mechanistic basis of natural
signal transduction.
Our work spans 3 methods of modulating expression and in each case seeks to overcome a major
engineering challenge by generating novel fundamental insights into the transduction mechanism through a
combination of high-throughput screening and machine learning. The first are Cas9-based synthetic
transcription factors, which enable targeted changes to the transcription of a gene. We plan to restrict their
activity via fusion to nuclear receptors that will make their nuclear localization, and hence regulation, conditional
on a chemical inducer. We aim to elucidate how the structure of nuclear receptors encodes their nuclear
trafficking kinetics and dynamic range, and then use these insights to design controls systems that can rapidly
implement strong regulation in response to a non-toxic chemical cue.
The second are ribozyme-based tools that regulate expression at the RNA level through splicing or trans-
cleavage. We plan to make their activity contingent on the presence of either native mRNAs, through template
dependent splicing, or chemicals, using aptazymes. We aim to understand how changes to the sequence, and
resulting structure, of these RNA devices alter their capacity to transduce their triggers into catalysis. The
resulting insights will be used to identify a combination of mutations that can overcome the low catalytic
efficiencies often associated with these tools.
The third are chemicals that activate human G-protein coupled receptors (GPCRs) to modulate
expression of the genes they regulate. We plan to identify plant metabolites that act as selective agonists by
developing a high-throughput screen that enables massively parallel characterization of GPCR-ligand
interactions. We aim to elucidate the design principles for functional expression of human GPCRs in yeast and
use the resulting biosensors to reveal the ligand features necessary for selective activation of GPCRs.
Overall, this research will create novel tools to enable precision control of gene expression and generate
fundamental insights into how molecular architecture, structure, and ligand specificity impact signal
transduction. Thus, it both aligns with the NIGMS mission and fills the need for “transcriptional control tools”
recently identified in the NIGMS NOSI: Synthetic Biology for Biomedical Applications (NOT-EB-23-002).

Public health relevance
Project Narrative While expression engineering tools have great potential to enhance fundamental science and medicine, the lack of effective ways to control their activity limits their utility. We aim to generate a deeper understanding of transduction mechanisms that could fill this need and use these insights to design better expression control tools.